INHIBITORY VISCERO-SOMATIC PATHWAYS BETWEEN THE GUT AND THE ABDOMINAL WALL

EMG recordings of the abdomen will be combined with a set of experiments that will feature distension regimens of the gut using a barostat or a latex balloon. It is proposed that IBS patients will respond abnormally to gut distension with excessive relaxation of the abdominal wall muscles.